FASEB's "The Lipid Droplets Conference"

Project Summary The 7th FASEB Summer Research Conference on Lipid Droplets, entitled “Lipid Droplets in Health and Disease,” will focus on the rapidly developing field of lipid droplet biology. Lipid droplets are dynamic cellular organelles that play key roles in energy metabolism. Lipid droplet accumulation and dysfunction are hallmarks of metabolic diseases, including obesity, lipodystrophy, insulin resistance, diabetes, nonalcoholic fatty liver disease, and cardiovascular disease. They are increasingly being studied in the contexts of cancer metabolism, neurodegeneration and immunity as well. The increasing prevalence of metabolic disorders throughout the world lends increased urgency to encouraging research into fundamental aspects of how lipid droplets form, grow, move, mature, and degrade and how lipid droplets influence cell, tissue and organismal physiology and contribute to disease. Understanding of these concepts is necessary for the rationale design appropriate new therapeutic strategies. The conference will be held from July 5-8, 2020 at the Snowmass Weston Hotel in Snowmass, CO. The format includes an opening night keynote address by Tobias Walther, six sessions of talks by invited speakers, as well as short talks by trainees and early career investigators selected from submitted abstracts, three poster sessions, a Career Workshop on career design and balance, and a Meet the Experts session on advanced imaging microscopy. The meeting format will encourage and facilitate interactions between trainees, early career investigators and established investigators. The scientific sessions cover the full breadth of lipid-droplet biology, from biophysical, biochemical, and cellular topics to physiology and disease. Talks from internationally renowned researchers will span basic to clinical research and describe diverse approaches (biophysics, genetics, biochemistry, cell biology, physiology) and models (mice, humans, cultured cells, flies, yeast). This meeting continues to represent THE major international meeting dedicated exclusively to lipid droplets and remains a unique forum for researchers to exchange ideas and share breaking results in this dynamic and timely field. A central aim of this conference is training and encouraging the next generation of scientists. This application requests funding to support the participation of 14 graduate students, postdoctoral fellows and early career investigators, including women, underrepresented minorities, and persons with disabilities, who will be chosen from submitted abstracts judged as superior. The intimate conference format, the secluded conference site, and the many opportunities for informal interactions between participants, planned and unplanned, will provide young investigators opportunities to present their work, to obtain feedback from leaders in the field, and to get career advice.

Public health relevance
Project Narrative Lipid droplets are fat-storing organelles involved in cellular energy storage and mobilization. Dysfunction or aberrant accumulation of lipid droplets is characteristic of human metabolic diseases like obesity, type 2 diabetes, non-alcoholic fatty-liver disease, and atherosclerosis, as well as some cancers and neurodegenerative disorders. In order to better understand lipid-droplet processes and form strategies to prevent and treat these conditions, the FASEB Scientific Research Conference on Lipid Droplets will bring together researchers from diverse scientific backgrounds and career stages to discuss critical issues in lipid- droplet biology; the overarching goal is to inform and encourage future research by the next generation of scientists.